Computational Design Engine for Accurate and Efficient Sequencing of DNA and RNA

PROJECT SUMMARY The need to develop low-cost, rapid, and high-quality technologies for sequencing mammalian- sized genomes has inspired many nanopore-based methods. All of these methods su er from two huge bottlenecks, which prohibit the required precision, and hence hinder the adoption of any of these methods as a practical technology as of today. These bottlenecks are: (1) undesirable noise levels for positioning DNA bases at read-out positions, and (2) di culty in controlling capture of large DNA molecules at the nanopore. By tackling these two critical challenges, we propose to build a Computational Design Engine (CDE) to enable sequencing of DNA and RNA at the maximum accuracy allowed by laws of physics. The rst aim is to reduce the positional noise of bases as DNA is being read. This goal will be accomplished by innovative implementation of ideas based on stochastic resonance, ratchet recti cation, protein-assisted noise reduction, and non-enzymatic electrostatic traps. The pro- posed CDE will be able to design optimum features of AC elds, on top of ratcheting forces from enzymes and voltage gradients. The second aim is to enhance capture of very large DNA and RNA molecules at the nanopore for subsequent sequencing. The construction of the engine will incorporate all critical components contributing to capture: entropic barriers, internal structures of RNA, entanglement e ects of DNA, electrostatics, electrohydrodynamics, and nano uidics. The engine will design the best experimental protocols, by optimum combinations of various contributing forces, to regulate the capture e ciency of very large DNA and RNA. For both aims, a broad suite of multi-scale modeling, and advanced theories of polymer physics and non-equilibrium thermodynamics, will be used in innovative ways. The proposed CDE will put theoretical bounds, based on sound laws of polymer physics, on sequencing accuracy in various methods being pursued and how to attain their maximum capacities, and to designing better alternative technologies.

Public health relevance
PROJECT NARRATIVE The proposed research is to build a robust Computational Design Engine as a key designing component in novel nucleic acid sequencing technology development. The construction of the engine will be based on sound laws of physics, incorporating various physicochemical concepts pertinent to sequencing of 150 kbp DNA and direct RNA sequencing. The Computational Design Engine will provide rational and innovative new designs for rapid and highest-accuracy sequencing of very large DNA and RNA.